Mouse Models of Fibroproliferative Lung Disease

ABSTRACT
The purpose of Core B - Mouse Models of Fibroproliferative Lung Disease and Sample Core – is to provide a
resource for the Program investigators to conduct studies in both in vivo studies with mouse models and in
vitro primary cell culture models. The Animal Core will be led by Dianhua Jiang, M.D, Ph.D., Professor of
Medicine at Cedars-Sinai Medical Center, who is currently a PI of the Animal Core for the PPG program in the
past years and has successfully supported all the projects. During the last funding period, the animal core has
successfully supported the three projects and achieved the proposed goals, and generated multiple mouse
strains required by all different projects and performed mouse modeling studies of lung fibrosis, resulting in
several high impact publications and forming the basis for renewal of this Program grant. The responsibility of
the Core includes providing training, standard operating procedures and facilitating for mouse models of
interstitial fibrosis and CLAD and developing a core unit to support these projects. Core B will unify the three
Projects by standardizing the aspects of animal experimentation and promote interactions among those
involved in the Projects. Core B will conduct treatments required to induce fibroproliferative lung disease in
mice and be responsible for outcome measurement. Fibroproliferative lung disease models will include
intratracheal bleomycin, mouse model of CLAD, and human lung fibroblasts from IPF patients to immune
compromised mice (SCID mice). Core B will isolate, fix and process mouse lung tissues and will perform
standard histology staining for lung inflammation and fibrosis measurement. Additionally, the Core will serve to
standardize histological scoring by implementing computer-automated assessment of lung hyaluronan,
collagen, airway remodeling, epithelial cell apoptosis and inflammation. Core B will isolate, maintain and
provide program investigators with primary cell lines including lung fibroblasts, macrophages and epithelial
cells from mouse models. This facility serves to standardize culture methods across the three projects. The
Core will also generate and maintain a mouse strain and results database, organize a tissue repository and
histopathologic analysis. Centralizing the animal work in the Animal Core will reduce the cost of producing
high-quality data and will facilitate interactions among the projects. Therefore, the Animal Core will play an
important role in unifying the three Projects by standardizing all aspects of animal experimentation and
promote interactions among investigators involved in the Projects to ensure the successful completion of
studies proposed in this Program Project.

Public health relevance
NARRATIVE The purpose of Core B - Animal Model and Sample Analysis Core – is to provide a resource for the Program investigators to conduct studies in both in vivo studies with mouse models and in vitro primary cell culture models. Core B will unify the three Projects by standardizing all aspects of animal experimentation and promote interactions among investigators involved in the Projects to ensure the successful completion of studies proposed in this Program Project.